Roles of BRCA2 in Mammalian Meiosis and Gamete Quality

PROJECT SUMMARY/ABSTRACT
Homologous recombination is an essential DNA repair process that facilitates accurate chromosome
segregation during meiosis, the specialized cell division that produces sperm and eggs. A fundamental gap in
our understanding of recombination during meiosis in mammals is the role the breast cancer associated
protein, BRCA2, which loads the central recombination enzyme RAD51 onto the ends of DNA breaks. This
knowledge gap persists because essential factors like BRCA2 are inherently hard to study, and reagents to
detect and analyze BRCA2 are limiting. These impediments are overcome in this proposal with the
development of genetic, genomic, and biochemical reagents and approaches to study the meiotic functions of
BRCA2. These include a fully functional epitope-tagged allele of the native Brca2 gene in mouse; high-
resolution mapping approaches to define BRCA2 binding sites genome wide; germ-cell specific Cre-lox mouse
lines to ablate Brca2 gene function at different stages of meiosis; and purified full-length human BRCA2 protein
and its partner proteins for biochemical analysis. Exploiting this unique constellation of tools, the long-term
objective of this project, to understand the roles and regulation of BRCA2 during meiosis in mammals, will be
pursued through three aims. Aim 1 will define the spatial-temporal binding patterns of BRCA2 and related
recombination factors using super-resolution immunofluorescence imaging, complemented by genome-wide
ChIP-Seq mapping. Aim 2 will determine the roles of BRCA2 throughout meiosis by inactivating the Brca2
gene in mouse spermatocytes and oocytes before, during and after meiotic prophase. Mutant phenotypes will
be analyzed using a battery physiological, histological, cell biology, and molecular assays. Preliminary data
support the hypothesis that BRCA2 functions at multiple stages of meiosis, and in the maintenance of ovarian
reserves. Aim 3 will define how a meiosis-specific chromosomal protein, SYCP3, modulates meiotic functions
of BRCA2 to optimize meiotic HR. Super-resolution imaging and genome-wide ChIP-Seq mapping of BRCA2
and related recombination factors will be performed in Sycp3 mutant mice. Biochemical assays with purified
human proteins will test the hypothesis that SYCP3 binds BRCA2 to facilitate the balanced assembly of
RAD51 and its meiotic homolog DMC1 at recombination sites to promote DMC1-catalyzed recombination
between homologous chromosomes. The results of these aims will provide unprecedented insights into the
missing biology of BRCA2 function during meiosis in mammals. These fundamental discoveries will be
germane to understanding pathologies associated with human meiosis, including infertility, miscarriage,
congenital disease, and premature ovarian insufficiency.

Public health relevance
PROJECT NARRATIVE The repair of programmed DNA breaks by homologous recombination is essential for meiosis, the cellular process that produces sperm and eggs. This proposal addresses a critical gap in our understanding of meiotic recombination in mammals, the role of the breast cancer associated protein, BRCA2, which loads the central recombination enzyme RAD51 onto the ends of DNA breaks. Defects in BRCA2-mediated recombination are associated with infertility, pregnancy loss, congenital disease and ovarian insufficiency.